Preventing Opioid Misuse through Safe Opioid Use Agreements between Patients and Surgical Providers (PROMISE ME)

1 In 2017, 191 million opioid prescriptions were dispensed in the United States of which a
2 significant portion were prescribed for acute pain management following surgical encounters. In
3 addition, on average, 70% to 90% of prescribed opioid pills following surgery remain unused
4 and over 70% of surgery patients do not dispose of their unused opioids. Unused pills are a
5 common source of nonmedical use; 54% of people obtain their pills for nonmedical use through
6 friends or relatives and 35% through their healthcare provider. Nonmedical use of opioids can
7 lead to Adverse Drug Events (ADEs), and is frequently a pathway to the use of other, illicit,
8 drugs such as heroin. Our research team is currently funded by the National Institute on Drug
9 Abuse (NIDA) to develop methods for decreasing opioid prescribing in surgery, and through this
10 ongoing research we have identified that even after decreasing the number of pills prescribed a
11 large number of pills still go unused. Given the variation in individual patient use and the
12 provider's desire to provide adequate pain control to all of her patients, this will likely continue to
13 be the case for the foreseeable future. Furthermore, very few patients safely store their opioid
14 pills or dispose of them correctly, even when provided information on the importance and
15 methods for taking appropriate action. As we consider the next phase of improving our opioid
16 prescribing practices, decreasing the number of pills prescribed cannot be the end of our best
17 practices recommendations but rather the beginning. Effective prevention of harm caused by
18 prescription opioids requires patients to safely use pills; using only the minimum needed to
19 control pain, safely storing them, and appropriately disposing of unused pills after acute pain
20 treatment.
21 This study, Preventing Opioid Misuse through Safe Opioid Use Agreements
22 between Patients and Surgical Providers (PROMISE ME), will test the use of contractual
23 agreements to improve safe opioid use to prevent misuse and opioid-related harm. We will (1)
24 assess the barriers and facilitators to implementing opioid use agreements in the surgical
25 setting, (2) measure implementation effectiveness outcomes and provide real-time improvement
26 strategies while we (3) test the effectiveness of the intervention using a step-wedged cluster
27 randomized trial. The study will have a significant impact on prescription abuse as it directly
28 addresses the availability of excess prescription opioids within the community which is the
29 primary source of misuse and harm. We will disseminate the new knowledge generated from
30 this study throughout our 56-hospital learning collaborative

Public health relevance
Project Narrative: Despite recent efforts to decrease the number of pills prescribed following surgery, patients continue to have a significant number of pills left over when their acute pain resolves. These excess pills too often end up being consumed for non-medical indications or diverted to individuals other than the intended user creating a significant patient safety problem. We will test the effect of an opioid use agreement to prevent misuse and opioid-related harm in the surgical setting.